Advanced Image Analysis Tools for Super-Resolved MRI in Small Animals

SUMMARY
Imaging in animal models plays a key role in biomedical research, enabling both foundational studies for
understanding disease processes, as well as translational studies evaluating novel therapies. In vivo imaging,
in particular, offers the benefits of minimal harm to the animal and opportunities for measuring developmental,
longitudinal changes. Magnetic resonance imaging (MRI) is one of the most extensively used in vivo imaging
modalities because of its excellent sensitivity to a multitude of biological parameters and flexibility with different
animal models, such as rodents, ferrets, and non-human primates. MRI has been used not only to advance
understanding of neurodegenerative diseases, but also aging, cancer, addiction, and cardiovascular disorders.
However, despite the research community’s desire for emulating clinical trials and performing high-throughput
studies, automated analysis of MRI in animal models has significantly lagged state-of-the-art tools that are
available in the analysis of human imaging. A major reason is that most animal MRI acquisitions are two-
dimensional with high in-plane resolution but thick slices, whereas the most powerful image analysis tools work
best on isotropic acquisitions. As a result, many researchers have been resigned to performing analyses
involving laborious, manual delineations.
Our team has recently developed a novel algorithm that uses deep learning to extract isotropic spatial resolution
from a standard anisotropic MRI acquisition possessing without the need for external high-resolution training
data, which is typically unavailable and difficult to procure. The ability to retrospectively recover isotropic spatial
resolution from these two-dimensional MRI acquisitions allows for significantly reduced costs compared to high-
resolution isotropic acquisitions. Moreover, it opens up the possibilities for more advanced analyses by enabling
key image processing algorithms, such as registration and segmentation, to be more accurately performed and
with greater automation. We therefore propose to perform the following Specific Aims in this R21 application: 1)
Optimize and evaluate our deep learning-based unsupervised super-resolution approach for animal MRI; 2)
Develop and evaluate a super-resolution algorithm for higher-dimensional data; 3) Publicly release the
developed tools. Our overarching hypothesis is that the provided tools will enable significantly more sensitive
imaging biomarkers, thereby increasing statistical power and reducing the size and cost of animal studies. The
combination of the proposed resolution enhancement with state-of-the-art techniques for image analysis will also
increase reproducibility by obviating the need for laborious, and potentially inconsistent manual delineations.
Furthermore, these efforts will enable both pre-clinical and clinical trials to be implemented with nearly identical
analysis pipelines. This application is being submitted in response to PAR 19-369, “Development of Animal
Models and Related Biological Materials for Research.”

Public health relevance
NARRATIVE Animal models are critical for developing new therapies and improving the understanding of a wide variety of diseases such as cancer, traumatic brain injury, and Alzheimer’s disease. Although magnetic resonance imaging enables monitoring of disease progression in animals, computational tools for extracting imaging biomarkers have lagged behind state-of-the-art tools available for clinical data, often because of limitations in spatial resolution. This project will develop and publicly release novel tools for improving the spatial resolution in animal images, leading to more robust, automated image analyses that will improve translation of animal studies to humans.